Single Cell Mosaic Mutation Atlas of Human Organ

PROJECT SUMMARY/ABSTRACT
Somatic mosaicism is a biological phenomenon that describes the presence of genetically distinct cells within a
subject. Mosaic mutations dictate numerous human phenotypes and are causal factors for a range of human
diseases such as autisim, cardiac disorders and cancers. Analysis of somatic mutations in normal tissues is
important for the understanding of both normal phenotype manifestations and the early onset of human
diseases. However, our current knowledge of the mosaic mutations is only the tip of the iceberg due to the
technical and computational challenges in detecting mosaic mutations with bulk genomic methods. In the past
3-5 years, high throughout single cell RNA sequencing (scRNA-seq) technologies have emerged as powerful
tools to dissect the cellular ecosystems of human tissues by profiling thousands of single cell transcriptomes.
The human cell atlas (HCA) projects have generated huge number of scRNA-seq datasets for many human
organs from eye to brain. Whereas these projects are focused on delineating cell types and cell states within
each tissue, they provide tremendous data resources to investigate the full spectrum of rare mosaic mutations
in human organs. The lack of robust computational tools presents as one major gap in knowledge to construct
a global mosaic mutation atlas of human organs from these data. Previous studies used bulk mutation calling
methods to perform single cell genotyping from scRNA-seq data, which however had low sensitivity that is
equivalent to bulk approaches. The central hypothesis is that rare mosaic mutations and their diversified
effects on cellular functions can be uncovered by genotyping single cells from scRNA-seq data. This project
has three major research goals: 1) Develop robust computational methods to accurately detect rare mosaic
mutations from scRNA-seq data. This includes a Bayesian method MosaiCopy for detection of copy number
variations, a toolkit MosaiTect for discovery of allele-specific point mutations, and a model-based method
MosaiMtTect to detect mutations in mtDNAs in individual cells. 2) Estimate the functional effects of mosaic
mutations in rare cells by developing a machine-learning software scGPS (single cell Genotype-Phenotype
Synergy). Additionally, this method will quantify the threshold of phenotype manifestation for each mosaic
mutation. 3) Genotype HCA datasets to investigate the cell type and cell state specific mutations and their
functions in affected cells of human organs. As a case study and validation of the results, the in-house heart
cell atlas datasets will be generated from healthy hearts (collected during heart transplantation). The overall
goal of this project is to develop novel computational methods to investigate the global pictures of mosaic
mutations and functional effects on cells of human organs. Successful completion of this project will lead to
new insights into the effects of genomic diversification on cell functions within human body. In long term, this
study will have significant impact on the development of novel prevention strategies for human diseases by
inhibiting the manifestations of clinical phenotypes at the very early stage of normal development.

Public health relevance
PROJECT NARATIVE Analysis of rare somatic mutations in normal tissues is important for understanding the manifestation of normal phenotypes and the genetic disposition of human diseases. This project aims to detect mosaic mutations from scRNA-seq data generated by human cell atlas and many related projects to quantify their prevalence and functional effects on the rare mutated cells. Our bioinformatic tools provide a cost-effective way to construct a full picture of mosaic mutation atlas of human organs, to understand the effects of genomic diversification on cell functions within human body, and to develop novel strategies to prevent the clinical phenotype manifestations of human diseases.